Administrative Core

Core A: Summary/Abstract The Administrative Core (AC) will coordinate all scientific, administrative, educational and outreach activities of the U-M Udall Center. The central objective of AC is to facilitate the realization of the scientific and educational goals of the U-M Udall Center. The Executive Committee (EC) of the AC will be the ultimate decision-making body for all Center administrative and scientific policies. The EC, composed of all Project and Core Leaders, will be assisted by the Internal and External Advisory Committees, which will review Center activities annually and provide a written review. Beyond its oversight of scientific, administrative and fiscal matters, the AC will also be responsible for the scientific training of all Center trainees, each of which will work under the supervision of a Project Leader and have their progress reviewed annually by the EC. The AC will also will work to widely publicize Center goals and discoveries; the principle vehicles for communicating this information will be the U-M Udall website, annual scientific and patient education symposia, and a novel electronic media approach.